Core C Protein Phenotype of Aging

CORE C: PROTEIN PHENOTYPES OF AGING – SUMMARY
This Core is designed to support to the Aging Research Community by providing access to state-of-the-art
proteomics technologies. The University of Washington Nathan Shock Center has been at the forefront of
developing technologies to perform large-scale discovery-based and targeted proteomics assays that generate
near complete data matrices, accurate quantitation, and high reproducibility – even across multiple
laboratories. The primary goal of Core C is to apply these methods to studies of aging, to obtain accurate
quantitative measurements of peptides from samples provided by its users, and to aid geroscience researchers
in linking these high-dimensional data to biologically meaningful outcomes. In addition, the Core will develop
and apply new assays especially suited to aging. This Core will work closely with Core D (Metabolic
Phenotypes of Aging), Core E (Invertebrate Models of Aging), and Core F (Explainable Artificial Intelligence for
Aging). We will collaborate with other NSCs and the broader aging research community as we have in the
past. In doing this, we will assist in the discovery of proteomic changes that underlie the biology of aging and
establish, disseminate, and aid in the implementation of new proteomics tools that allow us to advance studies
of aging. Furthermore, we will collect proteomics data that can be used to create biological aging clocks and
identify biomarkers that are associated with aging phenotypes.